EVALUATION OF SAFETY, PATIENT ACCEPTABILITY AND EFFICACY OF GLOBUMAN BERMA I.V.

The purpose of this study is evaluation of the safety, patient acceptability and efficacy of Globuman Berna I.V. intravenous gamma globulin in patients with primary immunodeficiency.